Implementation of SMART therapy for asthma patients in low-resource community health centers

PROJECT ABSTRACT
CANDIDATE: I am currently an Assistant Professor of Medicine in the Division of Pulmonary and Critical Care
at Washington University in St. Louis School of Medicine (WUSM). My career goal is to become an
independent, federally funded physician-scientist who utilizes rigorous implementation science and community-
based participatory research methods to improve the lives of patients with asthma, especially those from
disadvantaged backgrounds. To date I have received funding from the NIH Loan Repayment Program,
institutional T32 and KL2 awards, and the American Lung Association. While this past support has been
foundational, to reach my long-term goals, advanced training in implementation science and community-based
participatory research is required. In this proposal, I am mentored by world-renowned leaders in these areas.
Together, we have designed a research project and career development plan that, we believe, is impactful and
will provide me the training necessary to be competitive for R01-level, or equivalent, support before its
conclusion.
PROPOSED ENVIRONMENT: This proposal occurs within three complementary settings. First, this research
occurs at WUSM. To date, I have benefited immensely from WUSM’s career development resources and will
continue to leverage them to reach my career goals. The second setting for this proposal is the Brown School
at Washington University, which is one of the leading institutions for implementation science and community-
based participatory research. During a K23 award I will take two classes in advanced implementation science
methodology offered by its expert faculty. Finally, this study will be deployed within community health centers
in the St. Louis Integrated Health Network and complemented by didactic education and participation in
activities within the Center for Community Health Partnership and Research at WUSM.
RESEARCH ABSTRACT: The NHLBI’s asthma guideline body recommends single maintenance and reliever
therapy (SMART) for all patients with moderate/severe asthma. This recommendation is based on findings that
SMART decreases the risk of asthma exacerbations by one-third. However, within a network of federally
qualified health centers in St. Louis with whom we have partnered, <10% of asthma patients are prescribed
SMART. My team and I are developing and contextualizing a multi-level SMART implementation bundle, which
includes: clinician-level education with practice facilitation/supervision; an audit and feedback program; and
provision of patient-centered, electronic SMART education aides with updated asthma action plans. In this
proposed type 1 hybrid stepped-wedge cluster randomized trial, we aim to: 1) assess the effectiveness of the
SMART implementation bundle at increasing prescription of SMART (Aim 1, 1° effectiveness outcome), and
(2) utilize the RE-AIM framework to guide a quantitative and qualitative assessment of implementation
outcomes, including adoption (Aim 2, 1° implementation outcome).

Public health relevance
PROJECT NARRATIVE Asthma affects 25 million patients in the United States; however, the effects of asthma are inequitably experienced with asthma disproportionately burdening patients living in lower-resource communities. In this career development award, the candidate and his mentoring team will partner with a network of federally qualified health centers in St. Louis, Missouri to assess if the single maintenance and reliever therapy (SMART) implementation bundle improves providers’ prescription of guideline-recommend SMART (Aim 1, 1° effectiveness outcome) while concomitantly using the RE-AIM framework to evaluate implementation outcomes including adoption (Aim 2, 1° implementation outcome). The potential impact of this study is high for the scientific community, local community health centers, and the applicant as it provides the mentored training needed to prepare him to subsequently lead an R01-level hybrid effectiveness-implementation trial for guideline-recommend SMART therapy.